Essential Nurse Documentation: Studying EHR Burden during COVID-19 (ENDBurden)

PROJECT SUMMARY/ABSTRACT
This mixed-methods informatics study employs a series of data science methods triangulating data from
Interviews and EHR documentation, with the goal to identify essential documentation from the
COVID-19 pandemic and reduce EHR burden. EHR burden for registered nurses has been demonstrated by
increased documentation time, documentation amount, workload, and burnout and linkages to poor patient
outcomes. Decreasing EHR burden is a national priority, yet, there is no clear evidence to differentiate which
types of documentation are essential to support patient care. In recognizing the increased workload demands
during the COVID-19 pandemic, New York issued orders that relaxed documentation requirements for
clinicians, including nurses. Therefore, nurses’ documentation during the pandemic in New York reflects the
information deemed most essential by nurses – providing a unique and rare natural experiment to study
documentation burden. On the contrary, Missouri ranked as the 18th highest state for COVID cases overall,
and had no similar state orders. To advance the science, we will learn about nurses’ documentation from a
data science and informatics perspective, discover which documentation patterns (i.e., types, amount of data
entry and viewing) are deemed essential by nurses, and examine documentation pattern changes overtime
from before the pandemic through present day. We know that EHR burden exists, yet it is not understood
which documentation patterns explain and influence the relationship between patient care activities and patient
outcomes. We will use an EHR log-file time-based measure of patient care activities, operationalized as “total
shift time” minus “time spent documenting patient care activities or viewing data”. We will target respiratory
care management for acute and critical care patients and also include delirium care management for critical
care patients - applicable outcomes for both hospitalized COVID-19 and non-COVID-19 patients. The specific
aims are to: Aim 1: Examine changes in the temporal trends of data entry and data viewing patterns of nursing
documentation (e.g., types, amount) from 2019 through present day, inclusive of the COVID-19 pandemic
timeline. Aim 2:
Investigate how nurses define and decide what is essential to document for patient care
and the impact of all-inclusive documentation (i.e.,
documentation that meets both clinical and regulatory
demands)
on EHR burden
. Aim 3: Examine changes in data entry and data viewing patterns of nursing
documentation and the impact of these changes on patient care activities and patient outcomes, while
controlling for confounding factors related to workload, and nurse, patient, team, and organizational
characteristics.

Public health relevance
Project Narrative Nurses are burdened with the amount of data they need to document in electronic health records. We will analyze how nursing documentation changed when they were not required to document in specific ways during the COVID-19 pandemic. This project will help us improve documentation so nurses can focus more on patient care.